The Mutant Mouse Resource and Research Center at The Jackson Laboratory

ABSTRACT/PROJECT SUMMARY
This application proposes a renewal of the Mouse Mutant Resource and Research Center (MMRRC) at The
Jackson Laboratory (JAX). Highly sophisticated genome engineering technologies, a well-characterized
genome, mammalian physiology, and economical husbandry requirements make laboratory mice the mainstay
of biomedical research on disease mechanisms and disease modeling. The NIH has recognized that the potential
impact of genetically engineered mice for biomedical research cannot be fully realized without a centralized effort
to identify, archive, evaluate, characterize, and distribute valuable strains of mice to qualified biomedical
researchers. The MMRRC provides this centralized repository function. With over 94 years of mouse genetics
and resource experience, JAX joined the MMRRC in 2009 and has since been a key member of the consortium.
This proposal requests ongoing support for JAX as one of the four MMRRC core repositories. As a member of
the MMRRC consortium, JAX will contribute to the development and improvement of consortium-wide standard
operating procedures. The MMRRC at JAX will follow these mutually agreed upon standard operating
procedures to fulfill the goals of importation, archiving (through cryopreservation of sperm and/or embryos), and
distribution of biomedically important strains of mice and related materials. The MMRRC at JAX also provides
related services on a fee-for-service basis and conducts high-risk, high-return research and model development
projects that align with the overall goals of the consortium.

Public health relevance
PROJECT NARRATIVE The laboratory mouse remains the most powerful model organism for biomedical research due to its shared mammalian physiology and well-characterized and accessible genome. Advances in DNA sequencing and genetic engineering mean that the laboratory mouse can now be engineered with unprecedented speed and sophistication, such that now, more than ever, scientists rely on mice not only for basic research on disease mechanisms but also for direct modeling human genetic mutations in the context of complex mammalian physiology, gene-by-genome interactions, and pre-clinical drug testing. The Mutant Mouse Resource and Research Center (MMRRC) at The Jackson Laboratory serves as a biorepository for these valuable mouse models for the research community while providing leadership for best practices in mouse genetics, model development, and research reproducibility.